Linking cell forces to organ-scale morphogenesis of the small intestine

PROJECT SUMMARY / ABSTRACT
The lengthy small intestine is organized into compact loops within the confines of the body cavity in order to
achieve sufficient nutrient-absorbing surface area. Abnormal looping results in congenital gastrointestinal
disorders, such as midgut volvulus, which are often debilitating or lethal. During development, these loops form
by buckling, a common morphogenetic mechanism by which a tissue bends outward in response to compressive
mechanical forces. Elongation of the initially straight gut tube against the constraint of its attached membranous
mesentery results in compressive forces that buckle the tube into stereotyped loops. Loop morphology can be
predicted from experimental measurement of a handful of physical parameters, including mesentery stiffness. In
response to increasing stretch by the elongating gut tube, the mesentery is initially compliant before stiffening
and resisting further extension, thereby forcing the tube to buckle. This dependence of stiffness on stretch is
known as constitutive nonlinearity, a property well characterized in adult tissues but largely overlooked in
development, where its biological determinants are poorly understood. Here, we propose to elucidate key
biological bases of mesentery constitutive nonlinearity during small intestine looping. Preliminary data collected
by the applicant strongly implicates cell contractility in tuning the stiffening transition of chick mesentery, with
disruption of contractility surprisingly resulting in diminished mesentery compliance prior to unchanged stiffening.
Together with prior work showing similar changes upon inhibition of bone morphogenic protein (BMP) activity,
we hypothesize that BMP signaling induces cell contractility to tune mesentery pre-stiffening compliance (Aim 1)
and that extracellular matrix (ECM) compaction by these contracting cells sets the stiffening transition (Aim 2).
Experimental examination of this hypothesis will shed light on the mechanics of proper intestinal development
by integrating molecular control of cell behavior and matrix organization with organ-scale looping, which will yield
important insight into the etiology of gastrointestinal birth defects arising from improper looping.
In completing these Aims, the applicant will receive training in experimental techniques spanning developmental
biology and bioengineering, including chick embryology, molecular biology, immunochemistry, and soft tissue
mechanics. The applicant will participate in cross-department seminars, attend and present at engineering and
development conferences, and receive mentorship from the sponsor, co-sponsor, and advisory committee, who
contribute a diverse range of expertise. The applicant will also train in responsible conduct of research, oral and
written communication, mentorship, and many other career skills. This training will prepare the applicant for
postdoctoral research in academia studying the origins of physiological disorders for regenerative applications.

Public health relevance
PROJECT NARRATIVE The gut must have vast luminal surface area in order to absorb sufficient nutrients, and the small intestine achieves this, in part, by forming compact loops that permit the length of the gut tube to be far greater than that of the body. These loops form during development by mechanical compression of the tube by its attached membranous mesentery, and although errors in this process often result in fatal congenital gastrointestinal disorders, little is known about the biological processes and structures that determine the critical mesentery mechanics during looping. This project aims to elucidate how molecular regulation of cell contractility directs mesentery mechanics though active tissue reorganization in order to improve our understanding of the biophysical origins of abnormal intestinal looping.